Cis-regulatory mechanisms governing RORgt expression in type 3 lymphocytes

ABSTRACT
Type 3 lymphocytes include group 3 innate lymphoid cells (ILC3),
IL-17-producing γδ T cells (Tγδ17), and
T
helper 17
(
TH17) cells and are crucial for maintaining mucosal barrier defenses against extracellular bacteria
and fungi. Nonetheless, dysregulated type 3 lymphocyte responses have been implicated in the pathogenesis
of several autoimmune diseases, such as inflammatory bowel disease, Crohn's disease, and multiple sclerosis.
ILC3,
Tγδ17, and
TH17 cells are defined by their shared expression of the lineage-defining transcription factor
RORγt (Rorc(t)), which facilitates key inductive events during the development and differentiation of these cell
types towards the type 3 lymphocyte lineage. The trans-acting factor networks that cooperatively regulate the
formation of the type 3 lymphocyte cell types have been well characterized, however, the cis-regulatory
elements (CREs) that control the development and differentiation of type 3 lymphocytes remain less defined
Therefore, we are proposing a comprehensive assessment of the CREs controlling the expression of the
Rorc(t) locus across the type 3 lymphocyte lineage
cell types. To this end, we will
(i) identify the CREs
governing Rorc(t) expression using a high-throughput CRISPRi knockdown screen; (ii)
evaluate the activity of
Rorc(t) CREs using a retroviral massively parallel STARR-seq reporter assay; (iii) and determine the functional
role of putative CREs for the expression of Rorc(t)
in the
ILC3,
Tγδ17, and
TH17
cell types.
Altogether, the
experiments outlined in this proposal will expand our understanding of the cis-regulatory mechanisms
governing type 3 lymphocyte development and identity.

Public health relevance
PROJECT NARRATIVE Type 3 lymphocytes—including group 3 innate lymphoid cells (ILC3), IL-17-producing γδ T cells (Tγδ17), and T helper 17 ( TH17) cells—are crucial for a range of functions from mucosal barrier defenses against extracellular pathogens to secondary lymphoid organ formation. Their dysregulated function has also been implicated in various autoimmune diseases, such as multiple sclerosis and Crohn's disease. The proposed study will further our understanding of the regulatory mechanisms governing the development and differentiation of type 3 lymphocytes.